The danger signals in autoimmune uveitis

DESCRIPTION (provided by applicant): Autoimmune uveitis mediated by T cells is a major cause of blindness in the USA and worldwide, particularly among relative young and working populations. Proposed studies will focus on the danger signals in pathogenesis of chronic autoimmune uveitis using a murine model induced by the adoptive transfer of interphotoreceptor retinoid-binding protein (IRBP)-specific T cells. Aims described in this proposal will examine the release of danger signals initiated by uveitogenic IRBP-specific T cells, and the role of them in ocular inflammation. Aim 1 will determine the Fas/FasL signaling in rapid release of HMGB1 from viable retinal cells after interaction with IRBP-specific T cells. Aim 2 will examine the roleof HMGB1 in sustaining and promoting IRBP-specific T cell function during chronic intraocular inflammation. Results of these studies will further our understanding of the molecular pathogenesis of autoimmune uveitis and identify novel targets for anti-inflammatory intervention to limit visual loss.

Public health relevance
PUBLIC HEALTH RELEVANCE: Autoimmune uveitis is a common ocular inflammation mediated by auto-reactive T cells. Despite a wide range of local and systemic therapies to treat this disease, uveitis is still one of the leading causes of blindness in the Western world. Experiments described in this proposal will examine danger signals in the progress of T cell immunity in the eye. The long-term goal of proposed studies is to identify targets for interventional therapy for the disease.